Novel Bisphosphonate PET Probes for Myeloma Bone Disease

PROJECT SUMMARY/ABSTRACT
Multiple myeloma (MM), a malignancy of mature plasma cells, is the second most common hematologic
malignancy. Myeloma bone disease (MBD) is a devastating complication of MM. More than 80% of MM patients
suffer from destructive bone lesions, leading to severe pain, pathologic fractures, mobility issues, and
neurological deficits. MBD is not only a main cause of disability and morbidity in MM patients but also dramatically
increases the cost of management. While recent advances in MM therapy have significantly increased the
median survival of newly diagnosed patients, osteolytic lesions and their sequelae continue to be a major source
of patient morbidity and mortality, and bone pain is the most frequent presenting symptom of MM patients. Rapid
improvements in imaging technology now allow physicians to identify ever smaller osteolytic lesions and bone
marrow abnormalities, however the clinical value of anatomic findings is not always clear. Therefore, earlier
detection and more specific non-invasive assessment of treatment response is urgently needed, to assist in the
clinical decision-making process and enable treatment optimization for the individual patient (“personalized
medicine”).
In this exploratory R21 application we propose novel 18F-BP-PET imaging probes to provide MBD patients
a more sensitive measure of osteolytic lesions prompting them to take advantage of new treatment strategies
known to improve survival in this group. It is our goal to show that these innovative BP-PET probes can overcome
some of the disadvantages of current imaging strategies for MM and provide earlier diagnosis of MBD. Our long-
term objective is to translate this new platform into the clinic as a more effective probe for imaging, detecting and
staging MBD. Our innovative chemistry design offers rapid preparation (within one 18F half-life) of the proposed
PET probes. Cold chemistry will be performed at the USC UPC laboratories by Dr. Charles McKenna and his
team, and then elaborated for radiochemistry requirements with Dr. Kai Chen’s group at the USC HSC
laboratories. All radiochemistry, including in situ cyclotron generation of the radioisotope 18F, as well as the in
vivo animal studies and PET imaging will be performed under Dr. Kai Chen’s direction at the USC Molecular
Imaging Center. The optimized radiosynthesis procedure will be validated in an automated synthesis module for
future clinical production. To document the imaging efficacy of novel 18F-BP-PET probes, we will use 18F-FDG
and 18F-NaF as control imaging agents in a rodent model of MM which reliably results in related bone lesions
and compare them with our best novel probe to determine relative sensitivity, ability to detect early bone lesions,
specificity and aptness to monitor treatment response. The successful completion of these proof-of-concept
studies will serve as a solid foundation for next phase translational development.

Public health relevance
PROJECT NARRATIVE In this collaborative R21 project between the USC Keck School of Medicine and Department of Chemistry, a novel molecular technology for rapidly and efficiently introducing fluorine-18 into the P-C-P backbone of bisphosphonates will be developed for improved positron emission tomography (PET) imaging of myeloma bone disease, with the ultimate goal of reducing patient morbidity and mortality.